COMPARISON OF GAMMAR IVIG/PLACEBO IN DEMYELINATING POLYNEUROPATHY

To compare the respective responses to therapy of patients with CIDP after treatmetn with either IVIG or placebo utilizing the average muscle score as the primary efficacy variable.